Corneal Stromal-Epithelial Interactions During Fibrosis and Regeneration

DESCRIPTION (provided by applicant): Fibrosis, or scarring, is an evolutionarily developed method to rapidly close and repair a wound. Excessive deposition of extracellular matrix and the generation of contractile fibroblasts (myofibroblasts) characterize fibrosis. In the cornea, severe wounds that damage the basement membrane heal using fibrosis. However, in contrast to other tissues where function is maintained, fibrosis in the cornea leaves an opaque cornea that can impair vision. In the past funding period, we made the exciting observation that expression of integrin αvβ6 in the epithelium after wounding appears to play a major role in directing the fibrotic response in the cornea. Integrin αvβ6 binds to ECM, but more importantly also has the ability to activate TGF-β1 (T1) and -β3 (T3). These isoforms of TGF-β have been linked to stimulating (T1) and blunting (T3) fibrosis. Interestingly, our preliminary data indicate that a single application of T3 after wounding almost completely blunts the scarring response. The hypothesis we propose to test is: (1) Corneal epithelium stimulates HCF to undergo fibrosis in the absence of a basement membrane; (2) Integrin αvβ6 upregulation in the epithelium is a key component in the stimulation of a fibrotic response in the stromal cells and (3) Activation of TGF-β3 blunts this fibrotic response. We propose three specific aims to address the following questions. First, does corneal epithelium stimulate a fibrotic response by the stromal fibroblasts in the absence of a basement membrane? Second, is αvβ6 expression required for the stimulation of a fibrotic response? Third, does T3 inhibit fibrosis in corneal wounds? In vivo wound healing models in mice will be used to examine these questions. However, the majority of experiments will make use of an innovative co-culture model that combines human corneal epithelial cells with human corneal fibroblasts that have been stimulated to secrete a stroma-like matrix. Specific components of fibrosis will be examined along with signaling components of fibrosis. Immunofluorescence microscopy, real-time PCR, and TEM will be the major analysis tools. In addition specific inhibitors of αvβ6 expression and function will be used. Scarring processes to be examined include: myofibroblast generation, basement membrane reformation and ECM deposition. Relevance to Public Health - Over 10 million people world-wide suffers from blinding due to corneal scarring. Currently, no therapies are available except for corneal transplantation. Our studies will also evaluate if manipulating αvβ6 or if treating wounds with T3 can reduce corneal scarring in a human model. PUBLIC HEALTH RELEVANCE: Fibrosis, or scarring, is an evolutionarily developed method to rapidly close and repair a wound; however, in corneas, fibrosis leaves the cornea opaque and thus, non-functional. TGF-β1 (T1) has been linked to stimulating fibrosis and TGF-β3 (T3) to blunting it. Integrin αvβ6, which is known to activate both T1 and T3, is upregulated in the migrating epithelium that covers a corneal wound. Therefore, we propose to use a co-culture system consisting of human corneal epithelial cells and fibroblasts, as well as αvβ6-/- mice, to determine if epithelium directs fibrosis in the fibroblasts, if integrin αvβ6 is required to stimulte fibrosis, and if introducing T3 immediately after wounding will blunt the scarring response.

Public health relevance
Fibrosis, or scarring, is an evolutionarily developed method to rapidly close and repair a wound; however, in corneas, fibrosis leaves the cornea opaque and thus, non-functional. TGF-β1 (T1) has been linked to stimulating fibrosis and TGF-β3 (T3) to blunting it. Integrin αvβ6, which is known to activate both T1 and T3, is upregulated in the migrating epithelium that covers a corneal wound. Therefore, we propose to use a co-culture system consisting of human corneal epithelial cells and fibroblasts, as well as αvβ6-/- mice, to determine if epithelium directs fibrosis in the fibroblasts, if integrin αvβ6 is required to stimulte fibrosis, and if introducing T3 immediately after wounding will blunt the scarring response.